Center for Health Equity Research and Promotion (CHERP)

Background: The Center for Health Equity Research and Promotion (CHERP) is a Health Systems Research
Center of Innovation (COIN) representing a robust 23-year collaboration between the VA Pittsburgh Healthcare
System (VAPHS), Corporal Michael J. Crescenz VA Medical Center (CMCVAMC), and their respective
academic affiliates, the University of Pittsburgh and the University of Pennsylvania. In FY25-29, CHERP will
expand its groundbreaking research accomplishments in health equity and clinical therapeutics by integrating
cutting-edge dissemination and implementation science across all research endeavors. CHERP’s vision is that
all Veterans receive outstanding healthcare, the quality and accessibility of healthcare is distributed equitably,
and the VHA’s progress towards these goals is a paragon for healthcare systems nationwide. Our mission is to
advance the equity and quality of Veteran health and healthcare through impactful research facilitated by
partnerships, collaborations, engagement, mentoring, and service to the research enterprise.
Significance: Although the Veterans Health Administration (VHA) explicitly prioritizes connecting Veterans to
the “soonest and best care” and “driving equity for women, minority, and LGBTQ+ Veterans,” evidence-based
therapies are often not used appropriately or equitably. Our investigators rigorously apply their expertise in 5
Health Systems Research (HSR) areas of scientific inquiry (i.e., data science, engagement science, systems
science, implementation science, and policy analysis/evaluation) that advance VHA’s research priorities to
improve the quality and equity of health and healthcare for Veterans and support its evolution as a learning
healthcare system.
Impact Goals & Priorities: We propose Impact Goals (IGs) that address two HSR research priorities:
“behavioral, social, and cultural determinants of health” and “quality, safety, and value.” Our IGs are to: (1)
Improve the equity and quality of health and healthcare for marginalized Veteran populations and generate
evidence to inform related healthcare policies; (2) Increase the equity, accessibility, safety, and value of clinical
therapeutics for Veterans and generate evidence to inform related healthcare policies; and (3) Advance the
science and real-world application of dissemination and implementation methods to improve the equity and
quality of VHA healthcare. Our research has transformed related clinical practice and healthcare policy, and
our investigators lead 36 ongoing research and QI projects and plan 51 future projects aligned with these IGs.
Additional Contribution Areas: Our research has also improved clinical practice and informed health policy
aligned with the HSR priorities of “long-term care and aging” and “primary care practice and complex chronic
disease management.” Our investigators lead 19 ongoing projects and plan 31 future projects in these areas.
Innovation & Emerging Areas: Our investigators conduct leading-edge, partnered research by advancing the
science and real-world application of implementation science, creating unique data linkages and analytical
methods in data science, and studying the effects of VHA healthcare policy on healthcare disparities, patient
outcomes, and costs of care in policy analysis and evaluation.
Partnerships & Support for Research Enterprise: CHERP has developed 13 highly committed partnerships
that have persisted over time, supported multiple projects, and involved substantial financial contributions,
including VAPHS, CMCVAMC, VISN 4, and 10 national VHA Offices and Programs (e.g., Office of Health
Equity and Pharmacy Benefits Management). Collectively, these partners have invested $21 million over the
past 4 years to support partnered research and QI projects of mutual interest to improve the health and
healthcare of Veterans. As national thought leaders, our investigators contribute to the VHA research
enterprise by improving data quality, advancing research methods, developing new tools, and sharing technical
expertise with investigators and program leaders throughout the VHA research enterprise and beyond.

Public health relevance
The Veterans Health Administration (VHA) provides healthcare for individuals who are more likely to be racial and ethnic minorities, older, and poorer than the general population and ensures a healthcare safety net for these and other marginalized populations. Although VHA prioritizes providing high-quality, equitable clinical therapeutics and other healthcare services to all Veterans, evidence-based therapies are often not universally or equitably received. In addition to arising from individual, provider, and health system factors, such gaps in the quality and equity of healthcare delivery often originate outside of the healthcare system and involve social, community, and environmental influences. Investigators at the Center for Health Equity Research and Promotion (CHERP) use their expertise in data, engagement, systems, and implementation science to understand the root causes of these healthcare gaps, develop and implement interventions to improve the access and equity of healthcare for all Veterans, and support VHA’s evolution as a learning healthcare system.